Collaborative Care Office-Based Opioid Treatment for Adolescents and Young Adults

PROJECT SUMMARY:
Risk for opioid use disorder (OUD) often begins in adolescence and young adulthood. Engaging and retaining
adolescents and young adults (collectively, “youth”) in early, effective treatment to is critical in order to improve
the life course trajectory of addiction. For adults with OUD, office-based opioid treatment (OBOT) with a
collaborative care approach optimizes patient engagement and retention in care. This approach combines
physician visits, nurse care management, and behavioral therapy. Collaborative care OBOT is especially
promising for youth, who can receive treatment from a trusted primary care provider in the same familiar
setting they receive their usual medical care. To date, however, OBOT has not been formally adapted for
treating youth. The central objective of this project is to develop and pilot an OBOT model that is enhanced for
youth and that is developmentally appropriate and family-centered. The project includes: (1) an analysis of
Massachusetts Department of Public Health data to measure treatment patterns and outcomes among youth
with OUD, thus identifying periods of high risk for loss to follow-up and drug use relapse during treatment; (2)
qualitative interviews with youth, caretakers, and key informants (such as experienced OBOT providers and
primary care providers of youth in areas of high OUD prevalence) to determine necessary modifications to the
OBOT model for youth; and (3) a single-arm adaptive pilot study of OBOT enhanced for youth, using
implementation and improvement science techniques to optimize the intervention. The Principal Investigator,
Dr. Hadland, is an early career clinician-investigator with triple board certification in General Pediatrics,
Adolescent Medicine, and Addiction Medicine, and prior research experience in clinical epidemiology. With this
project, he seeks to enhance his skills in interventional research, focusing on developing analytic skills in
advanced survival analysis and use of correlated data, acquiring foundational knowledge in intervention
development, and using implementation and improvement science methodology to optimize an intervention
initially designed for adults for use among youth. Dr. Hadland will conduct this research at Boston Medical
Center and Boston University School of Medicine, national leaders in addiction medicine and research. The
project is supported by an interdisciplinary mentorship and advisory team with expertise in advanced
biostatistical analysis, qualitative research, intervention development, developmental psychology, and
implementation and improvement science.

Public health relevance
PROJECT NARRATIVE: Opioid use disorder frequently begins in adolescence and young adulthood, and early, effective intervention has the potential to improve the life course trajectory of addiction and its harms. This career development award application proposes to adapt the nationally-recognized Massachusetts Collaborative Care Model of office-based opioid treatment, which is evidence-based for the treatment of adults with opioid use disorder, to the treatment of adolescents and young adults. Through a systematic framework, the Principal Investigator will develop, implement, and iteratively improve office-based opioid treatment for youth to render it developmentally appropriate and family-centered.